Wichozani-A Healthy Lifestyle for Rural American Indian Youth through Cultural and Physical Activities: A Community-Based Participatory Research Study

Project Summary Community-based participatory research builds partnerships between communities and researchers to engage in research design, decision making, data collection, and dissemination of health promotion initiatives. This community-based participatory research project proposal, submitted through an NIGMS administrative supplemental funding opportunity, is a pat1nership with collaboration. Specifically, beginning the fall of 2020, INBRE-supported researchers within the South Dakota Biomedical Research Infrastructure Network (SD BRIN) and researchers in the Nebraska IDeA-CTR will collaborate with a rural American Indian community. The researchers will assess health disparities, including obesity and Type II diabetes within youth from ages 5 to 18, and will both implement and evaluate cultural and physical activity interventions. This youth physical activity program is an attempt to prevent future health complications and achieve health equity, or as the American Indian culture would rather say: achieve a culture of equality, harmony, and whichozani-a healthy lifestyle. Through this collaboration, training in the experimental collection, data analysis, and interpretation of physical activity data will be provided from Dr. Knarr's research group to the undergraduate SD BRIN fellows. Impo11antly, the SD BRIN fellows will receive hands-on experience in the collection of physical activity data through successful execution of this project, as SD BRIN students will be responsible for the experimental setup and retrieval of activity- monitoring devices. This training is highly complementary to the research focus of Dr. Smith and her team, whose expertise centers on the implementation of activity and health promotion programs.

Public health relevance
Project Narrative The Great Plains Area IHS and Tribal managed service units provide healthcare to approximately 130,000 American Indians located in North Dakota, South Dakota, Nebraska, and Iowa (IHS, 2019). Higher levels of physical activity are the most important strategies for preventing or decreasing childhood obesity and the health consequence of Type II diabetes. Fmthermore, physical activity continues to have ban-iers that influence successful physical activity programs for American Indian youth.